Metabolic Studies of Mouse Models of Obesity and Diabetes

The following projects have been supported by Mouse Metabolism Core in FY 2025:

1. DK075021
Role of G protein-coupled receptors in regulating glucose and energy homeostasis
Principal Investigator: Hans Jurgen Wess (LBC, NIDDK)

2. DK043313
Role of the Gnas Gene in Metabolic Regulation
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

3. DK043315
Role of Gs-alpha in central regulation of energy and glucose metabolism
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

4. DK043318
Role of Gs-alpha in pancreatic islet cell growth and function
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

5. DK075056
Role of Gq/11-alpha in metabolic regulation
Principal Investigator: Lee S. Weinstein (MDB, NIDDK)

6. DK031117
Development of drugs acting at adenosine receptors
Principal Investigator: Kenneth A Jacobson (LBC, NIDDK)

7. DK075057 DEOB
Physiology and pharmacology of BRS-3 (Bombesin Receptor Subtype-3)
Principal Investigator: Marc L. Reitman (DEOB, NIDDK)

8. DK075063
What can body temperature tell us about energy homeostasis?
Principal Investigator: Marc L. Reitman (DEOB, NIDDK)

9. DK075064
Role of brown adipose tissue (BAT) in energy balance
Principal Investigator: Marc L. Reitman (DEOB, NIDDK)

10. DK075017
Epigenomic regulation of adipogenesis and adipose expansion
Principal Investigator: Kai Ge (LERB, NIDDK)

11. DK075013
Nonalcoholic Steatohepatitis: Natural History, Pathogenesis and Therapy
Principal Investigator: Yaron Rotman (LDB, NIDDK)

12. DK075042
The role of PKD proteins in regulating tubular morphology
Principal Investigator: Gregory G. Germino (KDB, MIDDK)

13. DK054508
Regulation of hepatic and systemic immune responses
Principal Investigator: Barbara Rehermann (LDB, NIDDK)

14. DK055106
Transforming growth factor - beta superfamily signaling in diabetes and obesity
Principal Investigator: Sushil Rane (DEOB, NIDDK)

15. DK055107
Cell cycle regulators in diabetes and obesity
Principal Investigator: Sushil Rane (DEOB, NIDDK)

16. HD001010
Mechanism and Regulation of Eukaryotic Protein Synthesis
Principal Investigator: Thomas E. Dever (Section on Protein Biosynthesis, NICHD)

17. 19. BC005708
Xenobiotic receptors
Principal Investigator: Frank J Gonzalez (LM, NCI)